Acquisition of Shared Thermoneutral Rodent Housing Resources

PROJECT SUMARY/ABSTRACT
The need to house and maintain laboratory rodents under conditions of thermoneutrality, i.e., at the ambient
temperature at which energy expenditure is limited to that required to maintain basal metabolic rate, is
increasingly recognized as critical to achieving rigorous research outcomes. Evidence of temperature effects
on a vast array of physiological functions and pathologies spanning energy expenditure, immune function and
response, blood pressure, heart rate, sleep, food intake, tumor growth and resistance, and more have raised
awareness of the need to factor thermoneutrality into research designs to enhance the validity of research
findings and their translation to understand and enhance human health. To accommodate recent and ongoing
campus expansion of research capabilities for conducting biomedical studies in mice under thermoneutrality,
the University of Kentucky (UK) proposes to establish a Thermoneutrality Suite in its newest vivarium in the
recently constructed Healthy Kentucky Research Building (HKRB). The 3,000 sq. ft. HKRB vivarium supports a
265,000 sq. ft. six-floor state-of-the-art biomedical research facility that opened in 2018 and is contiguous to
animal facilities in two adjacent modern research buildings. The long-term goal of this equipment application is
to enhance and modernize animal research support operations managed by the UK Division of Laboratory
Animal Resources (DLAR) by equipping a three-room Thermoneutrality Suite (970 sq. ft. of space) with
dedicated advanced thermoneutrality caging. The proposed suite, to be operated by DLAR and overseen by
the Associate Vice President for Research Core Facilities, will achieve the specific aim to permit both the
breeding and housing of mouse colonies at thermoneutrality by acquiring six mobile Solace Zone IVC caging
systems to be installed in a 385 sq. ft. space adjoining two rooms equipped for experimentation under
thermoneutral study conditions. This request to the NIH will complement acquisition of separately acquired
thermoneutral experimental equipment to be consolidated in two adjacent rooms, but not part of this funding
request. The completed suite will elevate DLAR’s research-supporting operations for NIH-funded investigators
who studies require access to three Power Scientific Inc. model RIS70SD rodent experimental chambers to
support behavioral studies and four Actimetrics Clocklab Chambers suitable for performing circadian studies,
one of which is already in place. The HKRB vivarium is a modern, high-end facility. This facilities upgrade will
enable new research efficiencies and provide enhanced rigor to researchers whose study objectives require
carefully calibrated environmental conditions through an integrated research support operation. Addressing this
need for cutting-edge mobile animal housing units will impact diverse NIH-funded studies spanning cardiac
arrythmias, vascular dementia and neurodegeneration, skeletal muscle hypertrophy, metabolic disease, fetal
programming, and more to produce more rigorous study outcomes. These areas represent some of UK’s most
prominent areas of research activity conducted by a highly productive and collaborative faculty.

Public health relevance
PROJECT NARRATIVE A growing body of literature supports the breeding and rearing of and experimentation with mice at thermoneutral temperatures to better mimic a human-relevant response to the experimental condition. Most laboratory mice are housed at temperatures that are much lower than the environmental temperature at which mice do not have to generate heat, creating conditions of chronic cold stress that can change the outcomes of disease states. This request for six mobile individually ventilated caging systems that can house mice at thermoneutral temperatures, which are much warmer than standard room temperature for humans, will produce more reliable research findings that are more relevant to human disease.